PHASE 1 STUDY OF WEEKLY IV LOMETREXOL WITH CONTINUOUS ORAL FOLIC ACID SUPPLEMENT

To determine if administration of lometrexol weekly with continuous daily oral folic acid will permit investigation of lometrexol as an anti-cancer agent without toxicity.